Evidence of the burden of diabetes, gaps in the diabetes cascade-of-care and the impact of care and treatment on diabetes outcomes in HIV-positive and HIV-negative patients in South Africa

Project Summary
This proposed five-year development period will be used for research and training activities that will give Dr.
Brennan the skills and experience necessary to become an independent investigator. Dr. Brennan’s long-term
career goals are to use high volume, high variety and high velocity large-scale datasets to provide evidence for
the development of effective policies, programs and interventions to improve management and clinical
outcomes of patients with chronic communicable (i.e. HIV and tuberculosis) and non-communicable diseases
(i.e. diabetes, cardiovascular disease and chronic kidney disease) at a national level in South Africa. Although
Dr. Brennan is a clinical epidemiologist and methodologist by training, she recognizes the need and has a
strong desire to acquire applied data science and “Big Data” analytical skills to stay competitive in the field.
Building on her already strong background in quantitative data analysis, Dr. Brennan has proposed a training
plan to develop skills in novel applied data science methods to deal with large-scale data sets, primary data
collection, data validation and epidemiological approaches to causal inference. In addition, she has proposed
training in the clinical monitoring, diagnosis, treatment and management of metabolic and cardiovascular
conditions. The training plan will involve formal coursework, directed readings on specific topics, and strong
mentorship from experts in the field of metabolic disorders and HIV, domestically and internationally. The
proposed research will combine analyses of existing data from the National Health Laboratory Services in
South Africa, the sole provider for public sector labs, and patient-level data from a primary health care clinic in
the government sector. Upon successful completion of Dr. Brennan’s K01 award she will have started to build
an invaluable resource to assess the burden of non-communicable chronic diseases in South Africa. Dr.
Brennan’s high impact research is not only generalizable to other low- and middle-income countries, but would
also be relevant to high-income countries where similar populations exist, but not in the numbers necessary to
assess meaningful associations and interactions between desired exposures and outcomes. Through the
creation of this resource, in addition to further strengthening her quantitative skill set and clinical knowledge of
diabetes, Dr. Brennan will have developed competency as an independent researcher capable of securing R-
series NIH funding.

Public health relevance
Project Narrative Evidence is needed on the growing epidemic of type 2 diabetes mellitus, gaps in the diabetes cascade-of-care and the impact of care and treatment on diabetes outcomes in HIV-positive and HIV-negative patients with diabetes in low- and middle-income countries. I will use a probabilistic record linking algorithm to transform laboratory measurements used for monitoring and diagnosing diabetes (blood glucose and hemoglobin A1c) from South Africa’s National Health Laboratory Services database into a national prospective cohort of patients being screened for the condition and link to our existing national HIV cohort. The findings of this research will provide the necessary evidence for South Africa to understand the burden of the diabetes epidemic and begin to build effective policies, programs and interventions to improve management and clinical outcomes of patients in care and on treatment for diabetes.